GPI-ADAMTS13-Cultured Red Blood Cells

Project Summary/Abstract
We have developed PSC-RED, a chemically-defined scalable method to differentiate induced pluripotent
stem cells (iPSCs) into enucleated cultured Red Blood Cells (cRBCs) and we have demonstrated that we
can generate cells expressing a GPI-anchored, truncated fragment of ADAMTS13 that is able to efficiently
cleave its von Willebrand (VWF) cognate recognition site, while inserted in the cytoplasmic membrane.
The main objective of this proposal is to test whether transfusion of a few mL of therapeutic GPI-
ADAMTS13-cRBCs could replace plasma exchange as a treatment for Thrombotic Thrombocytopenic
Purpura (TTP). In Aim 1, we propose to produce cRBCs engineered site-specifically at the AAVS1 safe-
harbor site to express variant forms of GPI-ADAMTS13 that are resistant to the auto-antibodies
responsible for idiopathic TTP. We will validate the resistance of these GPI-ADAMTS13-cRBCs to a panel
of plasmas from untreated TTP patients, characterize their cellular properties, in vitro using a battery of
tests, and in vivo using a murine xeno-transfusion models based on injection of clodronate liposomes
(CloLip) and Cobra Venom Factor (CVF) that allows human RBCs to survive multiple days in the mouse
circulation.
In Aim 2, we will directly test whether GPI-ADAMTS13 red blood cells (RBCs) can be used to compensate
ADAMTS13 loss of activity in a fully immuno-competent animal model. We have engineered a mouse that
express GPI-ADAMTS13 specifically in RBCs from the rosa26 locus. We proposed to characterize these
cells and to transfuse them in a model of TTP based on injection of large amounts of recombinant VWF
into ADAMTS13KO mice. If successful, these key experiments will provide a proof-of-principle that
transfusion of RBCs carrying a membrane-bound ADAMTS13 can be used as a treatment for TTP.
We have shown that our protocol to produce cRBCs can be used to differentiate olive baboon iPSCs into
enucleated cRBCs. In Aim 3, we propose to characterize olive baboon GPI-ADAMTS13-cRBCs in vitro, and
to measure the half-life and the enzymatic activity of iPSC-derived GPI-ADAMTS13-cRBCs in vivo, in a large
animal model.
Engineered cRBCs are a highly promising avenue of translational research in the transfusion and the drug
delivery fields. Accomplishing the proposed Aims will provide pre-clinical data for a novel treatment for
congenital and idiopathic TTP. The proposed experiments will also validate a powerful platform to
produce and test therapeutic iPSC-derived cRBCs which could have many other applications.

Public health relevance
Project Narrative Red blood cells are life-saving because they can replace lost blood but they can also be used to carry drugs in the blood stream. We propose to produce from stem cells drug-carrying red blood cells that could provide a novel treatment for a deadly coagulation disease called TTP. These cells will be tested in mice and baboons to generate pre-clinical data that are necessary before human clinical trials can be conducted.